Progression of Social Cognitive Deficits in Mid- and Late-Life Schizophrenia Spectrum Disorders

PROJECT SUMMARY/ABSTRACT
Social cognitive deficits are prevalent in schizophrenia spectrum disorders (SSD) and significantly contribute to
poor community functioning. Since most people living with SSD are in their mid- and late-life and social
cognitive deficits often persist or even worsen over the course of illness, there is a critical need to develop
effective interventions for mid-late life SSD. Characterizing social cognitive deficits and their changes across
age and identifying neural markers are prerequisites to developing efficient identification strategies and
targeted neurobiological treatments. In response to RFA-MH-22-270 “Schizophrenia and Related Disorders
during Mid- to Late-life,” this project aims to advance knowledge in social cognition—one of the identified
priority research areas. We will recruit a large sample (n = 192; 50% female) of SSD participants in their mid-
late life (age 35 to 75). Additionally, 48 early-psychosis (age 18-34) and 120 age-matched non-psychiatric
participants will serve as clinical and healthy comparisons, respectively. Participants will complete
assessments of psychiatric phenotypes, neurocognition, and community functioning. Social cognition will be
assessed using a comprehensive battery capturing low- to high-level processes. A subset (75%) of the
participants will additionally undergo EEG during social cognitive tasks to determine the theta-band neural
oscillatory features underlying social cognitive deficits. The specific aims of this project are threefold: 1)
Delineate the age trajectories of social cognitive deficits in mid-late life SSD; 2) Evaluate theta-band neural
oscillatory features as neural markers of social cognitive deficits in mid-late life SSD; and 3) Parse
heterogeneity based on neural oscillatory signatures in mid-late life SSD. Successfully completing these
specific aims will advance our understanding of the course and neural mechanisms of social cognition in mid-
late life SSD, advancing NIMH’s Strategic Objective Objectives 2.1 (characterize the trajectories of cognitive
and affective processes across the lifespan), 2.2 (identify behavioral and biological markers of mental
illnesses), and 1.3 (identify neural mechanisms contributing to mental illnesses). The findings will guide
identification and personalized treatment strategies, providing critical knowledge to determine who and how to
intervene.

Public health relevance
PROJECT NARRATIVE Deficits in social cognition are highly common in mid- and late-life schizophrenia spectrum disorders, significantly contribute to difficulties functioning in the community, and are very difficult to treat. The goals of this study are to characterize social cognitive deficits, evaluate their trajectories in relation to normal and pathological aging, and discover neural markers underlying individual differences in these deficits in mid-late life schizophrenia spectrum disorders. The results of this study are expected to guide the development of better patient stratification strategies and targeted treatment interventions that improve social functioning for individuals living with chronic schizophrenia spectrum disorders.